Biomarker Core

The overall goal of the Biomarker Core is to collect, bank, and distribute fluid and cellular biospecimens and
generate biomarker datasets to address heterogeneity and improve diagnosis for Alzheimer’s disease (AD) and
AD-related dementias (ADRD). In doing so, the Biomarker Core will work closely with other Mayo ADRC Cores to
address our overall theme to study the “similarities and differences among neurodegenerative diseases”. During
the past funding cycles, the Mayo ADRC has been in the forefront in improving diagnostic tools and defining
clinical spectrum including normal aging, preclinical pathological changes, mild cognitive impairment (MCI), and
ultimately disease onset and progression. In addition to imaging biomarkers, our center has been collecting and
evaluating biomarkers measured in biospecimens including plasma, serum, and cerebral spinal fluid (CSF) to
define changes in the course of dementia development and progression. To further support and accelerate the
innovative discovery and translational research at Mayo Clinic and across the broad research community, we
aim to establish this new Biomarker Core to systematically bank and distribute biospecimens. We also aim to
generate and share critical biomarker datasets to enable research efforts in defining strategies for the early
diagnosis, prevention and treatment of AD/ADRD. In addition to fluid biospecimens, the Biomarker Core will also
collect, bank and distribute peripheral blood mononuclear cells (PBMCs), as well as PBMC-reprogrammed
induced pluripotent stem cells (iPSCs). This innovative element of the Biomarker Core will built upon existing
efforts and expertise through the Mayo Clinic Neuroregeneration Lab (MCNRL) where the Biomarker Core
Leader Dr. Guojun Bu also serves as the Director. We propose four Specific Aims for the Biomarker Core. In Aim
1, we plan to bank and distribute plasma, serum and CSF samples from ADRC participants subjects by
coordinating with the Clinical Core, and link sample information obtained through the Clinical, Neuroimaging, and
Neuropathology Cores. Another activity of this Aim is to evaluate requests and distribute biospecimens through a
Biospecimen Committee. In the second Aim, we plan to generate and publically share fluid biomarker datasets.
Both validated and emerging biomarkers in plasma, serum and CSF will be measured by Mayo investigators or
through collaboration and core services. In Aim 3, we plan to bank and distribute PBMCs for cellular biomarker
discovery and for reprogramming to iPSCs. In Aim 4, we will convert selected PBMCs to iPSCs for banking,
distribution and cellular biomarker discover. The reprogrammed iPSC lines will be selected based on research
interests in the AD/ADRD community and will consider unique genetic backgrounds of the donors (e.g., APOE
and TREM2 genotype). In addition to supplying iPSCs to investigators, the Biomarker Core will also provide
technical assistant and training for differentiation of iPSCs to different brain cell types and brain organoids.
Together, this comprehensive and innovative Biomarker Core will become an integral component of Mayo ADRC
to enable the discovery and validation of fluid and cellular biomarkers.